3D Bioprinting of Biomimetic Constructs for Rotator Cuff Augmentation

Project Summary
Rotator cuff tendon tears account for more than 4.5 million physician visits per year, and over 250,000 rotator
cuff repair surgeries are performed annually in the United States. For massive rotator cuff defect or chronic
tears with significant retraction and tissue loss, multiple strategies, including auto-, allo- and xenografts as well
as synthetic implants, have been used to augment the bone-tendon junction to improve the rates of successful
healing of these severe rotator cuff tears. Despite the current advances in tissue augmentation, the overall
failure rate has been reported to be between 38% and 65%. Obstacles in the development of approaches to
address tendon-to-bone healing are partly because (1) current augmentation options fail to mimic multizoal
structure of native rotator cuff tissue; (2) uniform matrix microenvironment impedes the heterogeneous
differentiation and vascularization of progenitor cells/mesenchymal stem cells (MSC); (3) limited knowledge
has been gained about how MSC differentiation status and vascularization pattern within different zonal region
affect rotator cuff healing. We have developed a novel strategy by combining 3D bioprinting technique with
biotextile technique to generate engineered rotator cuff constructs with zonal structure and spatial bioactive
factor distribution. The proposed studies will test the hypothesis that tendon-to-bone regeneration is enhanced
in vitro and in vivo by spatial differentiation of adipose derived MSC (ADMSC) and spatial control of
vascularization degree in pre-designed region in the optimized bioprinted microenvironment. The specific aims
of the studies are (i) determine how spatial differentiation of ADMSC within bioprinted rotator cuff constructs
affect tendon-to-bone healing; and (ii) determine how the spatially incorporated bioactive factors regulate
ADMSC differentiation, vascularization and rotator cuff repair. A massive rabbit infraspinatus tendon defect
model will be employed for both of the aims. The primary outcome measures will include inflammation,
construct integration, collagen fiber alignment, collagen types in different regions, muscle quality and fat
infiltration, and tensile biomechanics. This proposal will develop biological augmentation strategies to promote
scarless healing. Our approach is to better understand the roles of exogenous stem cells and vasculature on
tendon-to-bone interface regeneration in vitro and in vivo.

Public health relevance
Project Narrative Rotator cuff tendon tears are one of the leading causes of debilitating shoulder pain, but current rotator cuff grafts have high re-tear rates for massive defects/tears due to poor healing at the tendon to bone interface. This proposal will combine 3D bioprinting technique and biotextile technique to develop living, engineered rotator cuff grafts with zonal cellular and vascularization structure to mimic the native tissue and promote tendon-to-bone healing. The results of this project will seek to better understand the roles of exogenous stem cells and vasculature on rotator cuff healing in vitro and in vivo and have the implications for possible therapeutic application for other soft-to-hard tissue interface regeneration.